Steric-free labeling strategies to study disease-related non-histone substrates of post-translational modifications

Principal Investigator/Program Director (Last, first, middle): Wang, Ross, E.
Steric-free labeling strategies to study disease-related non-histone substrates of post-
translational modifications
The proposed research will utilize fluorine-based bioorthogonal reactions for steric-free labeling and chemical
biology interrogation of disease-related post-translational modifications (PTMs) such as acetylation and O-linked
N-acetylglucosamine. Despite recent advances in biomedical research, diseases are still haunting human
beings. Many cancer types remain lethal, particularly at late stages, and are resistant to traditional therapy, while
most inflammatory diseases result in chronic or long-term burdens, and there is a lack of selective
immunosuppressives on the market. Thus, there is a need for new therapeutic approaches by exploiting novel
proteins and protein-protein interactions (PPIs) as targets. Disease-related acetylation and O-GlcNAcylation
have recently emerged as important biological pathways that could unravel such potential targets. These PTMs
modify existing proteins with specific chemical functionalities to modulate protein function, and thereby mediate
various cellular activities including activation, proliferation, and migration. Dysregulation of the related proteins
has been reported to be key to certain human diseases such as cancer and inflammatory disorders. Yet, the
identity of these non-histone proteins and PPIs has not been fully elucidated. Current research in this area is
still at a preliminary stage, heavily relying on chemical proteomics, which directly tags target proteins within
complex proteomes with alkyne or azide- modified pro-metabolites such as acetyl-CoA or glucosamine. These
chemical tags, after their metabolic labeling onto protein substrates, can later be derivatized in situ through bio-
orthogonal ‘click chemistry’ with a fluorophore for imaging or a biotin affinity probe for pull down and proteomics-
based target identification. However, these alkyne/azide- based tags are bulky in length and size, and for many
cases cannot be metabolized by PTM enzymes and were barely incorporated onto substrates, thereby limiting
the related target identification.
The proposed research will focus on developing an innovative chemical tagging approach which is steric free
and can be broadly used for the global profiling of proteins and PPIs related to acetylation or O-GlcNAcylation.
We hypothesize that unlike azides and alkynes, fluorine labeling can best mimic the intrinsic carbon-hydrogen
bond and is thereby steric free and generally applicable to tag acetylation and O-GlcNAcylation. The first
research thrust seeks to utilize the fluorine-displacement reaction toolkit to systematically interrogate acetylation-
involved proteins and PPIs in breast cancer and T-cell activation. The second research thrust involves the new
methodology development by combining the fluorine-displacement reaction toolkit with specific inhibitors of the
acetyltransferase so that one can specifically label and profile potentially novel substrates and PPIs downstream
of that isoform-specific acetylation enzyme. The fluorine displacement based chemical proteomics approach will
also be tested on O-GlcNAc substrates to reveal novel PPIs related to prostate cancer. The final thrust will
investigate new generations of fluorine-mediated chemical reactions for PTM labeling.
Page 1

Public health relevance
Project Narrative This proposed project combines interdisciplinary cutting-edge technologies in synthetic chemistry, molecular biology, enzymology, biochemistry, and cell biology to push the boundary of our understanding of post- translational modifications related to the onset and relapse of human diseases, using steric-free bioorthogonal labeling strategies. This study will provide invaluable insights into complete sets of the substrate proteins, the protein-protein interactions including the corresponding PTM enzymes for acetylation and O-GlcNAcylation, which could be applicable to deciphering and controlling many diseases affected by irregular post-translational modification signaling.